Immune-adipocyte Crosstalk in Adipose-selective Thermogenic Program

Project Summary
Immune cells are an integral part of the adipose microenvironment and have pronounced effects on the
expansion and activation of thermogenic adipocytes, also known as beige/brite adipocytes. Anti-inflammatory
factors are postulated to be beneficial for insulin resistance and diabetes. Our lab recently reported that ablation
of interleukin-10 (IL10)-associated anti-inflammatory signaling in mice, surprisingly, improved insulin sensitivity
and glucose tolerance, protected against diet-induced obesity, and elicited browning of white adipose tissue. My
proposal builds upon comprehensive data to address the crosstalk between immune cells and adipocytes within
adipose tissue depots in regulating adipose thermogenesis. Our published and pilot studies show that interfering
with IL10 activity in adipocytes is associated with increased thermogenesis, mitochondrial respiration, and
energy expenditure. Ablation of adipose T cells increased adipose thermogenesis, pointing to a hematopoietic
origin of the IL-10 signal regulating adipose tissue function. The IL10 receptor alpha (IL10R) is highly expressed
in mature adipocytes, and adipocyte-specific knockdown of IL10R decreases fat mass and increases adipose
thermogenesis, energy expenditure, and lipolysis. Conversely, IL10 treatment directly antagonizes the
expression of thermogenic and lipolytic genes in a cell-autonomous manner. Furthermore, genome-wide Assay
for Transposase-Accessible Chromatin (ATAC)-seq, ChIP-seq, and RNA-seq demonstrated that IL-10 represses
the transcription of thermogenic genes by altering chromatin configuration at key enhancer and promoter regions.
Our findings identify the “IL10-IL10R axis” as a novel regulator of the thermogenic transcriptional program in
adipose tissue and challenge conventional assumptions regarding links between immune and inflammatory
signaling and adipose tissue function in obesity. To further test the hypothesis that adipose-specific IL10R
directly “senses” IL10 in the microenvironment to limit adipose thermogenesis and promote obesity-related traits
I propose three Specific Aims: i) to define the therapeutic potential of ablating IL10R in the adipocytes of adult
obese mice; ii) to identify IL10 secreting immune cells, and iii) to determine the mechanism by which IL10 controls
adipocyte thermogenic program. Immune cells are an integral part of the adipose microenvironment; thus,
studying how IL10 modulates adipocyte regulatory processes should advance our knowledge beyond
inflammation and anti-inflammation and inform future therapy for obesity and insulin resistance.

Public health relevance
Project Narrative (Relevance) White adipose tissue has an inherent plasticity to turn on the heat generating brown adipocyte gene program to increase energy expenditure. Therefore, understanding and manipulating the biological programs governing distinct adipose thermogenic cell phenotypes may have therapeutic potential to combat obesity and Type 2 diabetes.